Spatial subcellular mapping of the intestinal LncRNAome

PROJECT SUMMARY
Current ulcerative colitis (UC) treatments only alleviate symptoms and maintain remission of UC. Thus, studies
to identify new regulatory factors are required. Long noncoding RNAs (lncRNAs) account for a significant
proportion of the human genome and have been implicated in the development of chronic and inflammatory
diseases. To date, a small number of studies have indicated that lncRNAs play a role in regulating intestinal
epithelial barrier integrity, and lncRNA expression has been shown to correlate with disease progression in UC.
Yet, the physiological functions of lncRNAs in the pathogenesis of UC remain unknown. Recent studies indicate
that lncRNAs can localize to specific organelles and regulate cellular metabolic pathways. However, there is a
significant gap in our knowledge of the physiological function of these subcellular lncRNAs in the tissue
microenvironment.
During my postdoctoral studies in the laboratory of Dr. Kate Fitzgerald at UMass Chan Medical School, I identified
a novel transcript of the lncRNA HOXA11os that translocates to the mitochondria in colonic cells. Through direct
interactions with proteins associated with the Krebs cycle and complex I of the electron transfer chain,
HOXA11os regulates oxidative phosphorylation and ATP production in the distal colon to restrict intestinal
inflammation. This study pioneered our understanding of lncRNA function in colonic tissue and provided the first
evidence of a lncRNA that localizes to the mitochondria to regulate its activity. The question remains whether
additional lncRNAs localize to other organelles and regulate metabolic pathways. Thus, the overall goal of this
proposal is to identify and characterize organelle-residing lncRNAs that regulate tissue homeostasis
and inflammation through direct regulation of organelle function and metabolic pathways.
This proposal is focused on three Research Areas. The first Research Area will focus on identifying endogenous
lncRNAs that localize to organelles and the molecular mechanisms regulating their subcellular trafficking and
organelle import. The second Research Area will focus on characterizing the precise molecular mechanisms by
which organelle-residing lncRNAs regulate protein activity in metabolic pathways associated with UC. The third
Research Area will focus on identifying the physiological role of organelle-residing lncRNAs in the onset and
progression of UC to target them for treating UC. Together, these studies will identify novel lncRNAs that regulate
the function of metabolic organelles to maintain homeostasis and restrict intestinal inflammation.
The goals of this proposal are highly relevant to the mission of the NIAID and will enhance our understanding of
distinct lncRNA biology in the colon microenvironment. Ultimately, this work will aid in the design and
development of therapeutics for the treatment of UC and will potentiate future studies to assess the role of
organelle-residing lncRNAs in other inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Current treatments for ulcerative colitis (UC) only address the symptoms or maintain remission of the disease; thus, new prevention and treatment strategies are urgently needed. Targeting long noncoding RNAs (lncRNAs) to treat UC is a promising strategy, as lncRNAs have been associated with intestinal inflammation. The proposed research will identify candidate lncRNAs involved in UC, determine where they are localized in human biopsy samples and mouse models, and elucidate their function and role in disease pathogenesis, leading to new drug targets to alleviate the burden of UC and other intestinal diseases.